Childhood Hematological Malignancies Training Program

PROJECT SUMMARY/ABSTRACT
Hematological malignancies are the commonest childhood tumors, and despite remarkable advances in survival
rates, remain a leading cause of cancer death. The last decade has witnessed great progress in understanding
the genetic basis of these tumors, but translating these discoveries into mechanistic insight into the basis of
tumorigenesis and treatment response, and into new diagnostic and therapeutic approaches remains limited.
Advancing outcomes for children with hematologic malignancies is reliant on training independent investigators
with expertise in genomic analysis, experimental modeling, translational science and preclinical modeling of
childhood hematological malignancies. Although some T32 training program provide training in childhood cancer,
none are solely devoted to training in hematological malignancies or a training program that utilizes the rich
foundation of genomic discoveries from the Pediatric Cancer Genome Project. The proposed training program
will equip the next generation of scientists with the skills and knowledge from multiple disciplines to become
leaders in the field of childhood hematological malignancy research. The proposed program will train three
postdoctoral fellows in the first three years, and four fellows in years four and five, with an additional position
supported by St Jude. The program will provide an enriched training experience supported by faculty with diverse
expertise, including mentorship teams for each trainee consisting of scientific and clinical investigators; a T32
Internal Executive Committee that reviews program progress and assists with training program development and
coordination of training activities; an External Advisory Committee comprised of five national leaders in childhood
cancer research and postdoctoral training; a dedicated lecture/seminar series providing training in genomics,
genetics, pathology, biostatistics, experimental modeling, genome editing, immunotherapy, preclinical studies
and clinical trial design; a trainee day featuring trainee and invited speaker presentations; training in scientific
and grant writing; the requirement that trainees submit external grant funding applications no later than the
second year of the fellowship; and detailed evaluation of the progress of trainees. Trainees will be closely
integrated with the rich portfolio of basic to translational research activities of the St Jude Comprehensive Cancer
Center Hematological Malignancies Program, which coordinates translation of basic science discoveries to
clinical trials. This program will provide an unrivalled opportunity to train scientists to address critical unmet needs
in childhood hematological malignancies.

Public health relevance
PUBLIC HEALTH RELEVANCE – This proposal aims to enhance research training for young scientists to promote the next generation of independent investigators studying childhood blood cancers. Advanced approaches in genomic analysis, experimental modeling and translational research will be integrated to enhance training for scientists early in their research career. The long-term goal is to improve understanding and treatment of childhood blood and lymph cancers by advancing research progress in this field.